Molecular determinants of Streptococcus pyogenes adhesion to pyroptotic keratinocytes

PROJECT SUMMARY
Streptococcus pyogenes (Group A Streptococcus, GAS) is a gram-positive obligate human pathogen and a
significant public health burden. GAS causes diverse infections, ranging from relatively mild skin (impetigo) and
throat (strep throat) infections to severe infections such as necrotizing fasciitis (“flesh-eating disease”) and
streptococcal toxic shock syndrome. GAS strains are divided into more than 200 M types based on the variable
surface protein M, as well as 9 fibronectin binding, collagen binding, T-antigen (FCT) genetic region types based
on their surface pili. Some strains are specifically associated with either skin or throat infections, while others
can infect either tissue. Tissue tropism is associated with emm genes and FCT genetic regions, but the precise
molecular determinants for tissue tropism are unknown. This work will study host and bacterial determinants for
GAS adhesion to skin cells. Additionally, keratinocytes trigger pyroptosis, a programmed cell death, in response
to intracellular GAS. This work will also examine the effect of keratinocyte pyroptosis on GAS adhesion, and
whether this contributes to infection mitigation. I hypothesize that keratinocytes vary in their exposure of targets
for GAS adhesins throughout their differentiation and death, and that this consequently impacts GAS invasion of
the skin. Aim 1 will examine GAS adhesion to keratinocytes and identify whether differentiation and death of
these cells impact GAS adhesion. Aim 2 will reveal GAS adhesion factors using transposon screening to identify
putative genes encoding adhesion determinants in GAS. These will be validated with genetic knockout and
complementation experiments. The mentor for this F31 proposal, Christopher LaRock, has extensive experience
studying pyroptosis resulting from GAS infection. This work will build on this discovery to identify factors
influencing how mild infections can turn severe, determinants of infection resistance, and provide training for the
PI Jacob Sherman in techniques of modern molecular Koch’s postulates for a research career in human health.

Public health relevance
Project Narrative: Streptococcus pyogenes is a major cause of human disease worldwide. This project aims to understand how the pathogen Streptococcus pyogenes adheres to skin cells as they trigger their built-in defenses. Understanding the molecular basis for this host-pathogen interaction gives insights into its epidemiology, its virulence requirements, and targets for better treatment and antiseptics.